Developmental Research Project Program

Developmental Research Project Program Summary/Abstract
The ND INBRE has provided over 1,000 students an undergraduate research experience. Over 50% have
been on the campuses of the PUIs and TCUs. The research experiences of the PUI and TCU students
were provided year-round by pilot grants from the developmental grant program. This effort has
resulted in over 400 poster presentations by the students. The students also display high graduation
rates with a large majority of students entering research and the health professions. Noteworthy is the
entry of 25 M.D.’s and 41 Ph.D.’s into the workforce. The ND INBRE will keep the successful PUI and
TCU pilot grant program in place during the upcoming funding cycle. The study section review did
question what the program has provided for UND. In response to this valuable question, the ND INBRE
proposes to support a new developmental grant program to stimulate faculty development at UND
based on the K99/R00 program of the NIH. Previous efforts by the program have centered on
infrastructure development and the K99/R00 provides entry of the program into faculty development.